Career Enhancement Program

Career Enhancement Program SUMMARY/ABSTRACT
The central goal of the Career Enhancement Program (CEP) is to use the resources at MD Anderson to train
exceptional young investigators who will reduce the morbidity and mortality from ovarian cancer by making
advances in the early detection, prevention, and treatment of this disease. To achieve this goal, the SPORE
CEP will provide two awards, each of $50,000 annually for up to two years, funded from the SPORE and
matching funds from MD Anderson. The intent of each CEP award is to prepare the selected scientists to become
international leaders in academic research relevant to ovarian cancer. We will achieve this through focused
recruitment of a diverse cadre of promising young investigators. We will work in partnership with awardees to
generate individualized development plan and provide them with outstanding clinical and a laboratory mentors
and a mentoring committee, formal course work, coaching in grant and paper writing, leadership training,
attendance at national meetings, networking with ovarian cancer scholars and completing and publishing a
translational ovarian cancer research program. Over the past two decades, the Ovarian Cancer SPORE CEP
has developed the careers of 27 young investigators. In the first year of the original grant, three postdoctoral
trainees received CEP awards, and of the 24 faculty members supported since 2000, all but two have remained
in academic research and 13 are engaged predominantly in ovarian cancer research. Seventeen have achieved
federal peer-reviewed funding and five additional awardees have received competitive foundation grants. Three
awardees from our 2017-2021 funded cycle have received two Ovarian Cancer Research Alliance (OCRA)
Awards, one CPRIT award, one R01, one R21, and one U01. Since the inception of the program in 1999, our
CEP awardees have published over 1,100 peer-reviewed papers regarding ovarian cancer.